Mechanisms of Cellular Morphogenesis that Coordinate Signaling during Tissue Patterning

Project Summary
The long-term goal of our research program is to understand and identify the mechanisms of cell shape
dynamics that facilitate the emergence of tissue-wide patterns from local cell-cell communication events. The
incorrect spatial and temporal induction of genes and cell behaviors by perturbed signaling can lead to
catastrophic errors in development. Therefore, it is critical to understand how signaling mechanisms that take
place at the level of a cell or adjacent cells are coordinated across larger tissue length scales to achieve robust
patterns and support tissue homeostasis. Cytonemes, or signaling filopodia, are long actin-rich cellular
protrusions that allow cells to physically interact with, and signal to, other cells at a distance. Cellular
protrusions like cytonemes have been shown to play a role in many developmental processes, including spot
and stripe patterning, limb patterning, stem cell niche maintenance, and neural plate patterning. Despite this,
relatively little is known about the general mechanisms that regulate cytoneme-specific formation and behavior.
We are interested in understanding how these protrusions are regulated both at the level of cytoskeletal
mechanisms, and as an integrated part of the cell-wide and tissue-wide signaling states. To address this
problem, we use the spot pattern of bristles on the dorsal thorax of the fruit fly Drosophila melanogaster as a
model system. During bristle patterning, cytonemes extend from the basal surface of thoracic epithelial cells to
facilitate long-range, Notch-mediated, lateral inhibition. Leveraging our strengths in Drosophila model systems
genetics and quantitative live microscopy, over the next five years our goals include understanding how the
formation of cytonemes are regulated, especially downstream of Notch-mediated lateral inhibition signaling. In
parallel, we aim to understand how cytoneme activity contributes to cell and tissue heterogeneities that
facilitate the timely formation of well-organized patterns. These studies will not only yield valuable cell
biological knowledge about the specific regulation of cytonemes, but will also elucidate fundamental
mechanisms that coordinate patterning across length scales.

Public health relevance
Project Narrative Biological patterning relies on the coordination of cell-cell communication events across large and small distances, and defects in patterning can lead to human disorders and disease. Cytonemes are one example of an active cell process that coordinates cell signaling for many patterning events during vertebrate and invertebrate development. The goal of this work is to understand both how cytonemes are regulated at the cellular scale and how they contribute to the overall progression of patterning.